Bactericidal antibiotics targeting lipoprotein transport in Gram-negative bacteria

Project Summary/Abstract: Our research is focused on the synthesis and biological study of antibiotics to
address the growing problem of modern multi-drug resistant (MDR) pathogens of critical threat. By introducing
three key structural variations within the scaffold of an established inhibitor of the localization of lipoproteins (lol)
pathway, we have synthesized novel antibiotics with superior potencies against MDR Escherichia coli (E. coli)
and Klebsiella pneumoniae (K. pneumoniae). Crucially, these more potent antibiotics induce a much lower
frequency of spontaneous resistance in E. coli (FoR ~10-9) than the previously reported inhibitor (FoR ~10-7). We
propose to diversify and improve the modular platform we have developed to synthesize large numbers of
candidate antibiotics with improved potencies and optimized pharmacokinetic and pharmacodynamic profiles,
which will be evaluated with in vitro and, where appropriate, in vivo studies. Furthermore, we aim to deepen the
understanding of the mechanism of action of our molecules by cryo-EM imaging of the molecules bound to their
target, the lolCD2E lipoprotein transport machinery. This will also inform structure-based design of future
antibiotics candidates.

Public health relevance
Project Narrative: Our research aims to design, synthesize, and evaluate the mechanism of action of novel antibiotics that are effective against Gram-negative pathogens resistant to most or all antibiotics used in the clinic. Research in our lab has identified a novel antibiotic that acts through a novel mechanism of action to kill species of Gram-negative bacteria which are resistant to nearly all known antibiotics. We aim to use this lead to develop antibiotics with improved potencies and pharmacological properties to combat the growing global health crisis of antibiotic resistance.